Cell-type specific role of melanocortin 4 receptor in inflammation and cognition with aging

Low-grade, chronic inflammation (“inflammaging”) is a pillar of aging, with neuroinflammation in the
hippocampus associated with decreased cognitive ability and decreased lifespan. Feeding rodents a high fat
diet (HFD) mimics the neuroinflammation, shortened lifespan, and compromised cognitive ability similar to
what is seen with aging. However, the molecular mechanisms responsible for central inflammaging remain
elusive despite their crucial role in health- and lifespan. Melanocortins (MCs) are neuropeptides that have
major roles in body weight homeostasis but are also anti-inflammatory and increase cognition, and decrease
amyloid beta levels and neurodegeneration. Endogenous MC expression decreases with age, providing a
plausible mechanism to explain increased obesity, decreased cognition, and increased inflammation with
aging. MCs decrease inflammation by blocking activity in the same inflammatory pathways and production of
mediators of inflammation. MCs act on melanocortin 4 receptors (MC4R) found predominantly in the brain on
both neurons and astrocytes, with little expression in the periphery. Our preliminary data show that
administration of an MC4R agonist to 18-month-old mice decreases inflammation in the hippocampus and
increases cognition. However, it isn’t known if these beneficial effects of MC4R agonists are mediated through
astrocytic or neuronal populations. Our lab has also found that deletion of MC4R only on astrocytes in the
hippocampus is sufficient to induce inflammation measured by an increase in microglial activation.
Surprisingly, development of MC agonists as an intervention to slow aging is largely unexplored, likely due
to a lack of understanding of how MCs mediate these effects at a cell-type specific level as there is no data
linking astrocytic MC4R to inflammation in aged populations. Our objective is to define the role of astrocytic
and neuronal MC4R populations in inflammaging both molecularly (astrocyte reactivity, microglial activation,
synaptic health, and inflammatory pathways) and behaviorally (cognition and reward learning). We hypothesize
that astrocytic, but not neuronal populations of MC4R mediate age-induced hippocampal inflammation. We will
use a combination of genetic mouse model with a transcriptional blocker for MC4R with viral vector-mediated
excision of the transcriptional blocker to rescue MC4R expression in a site- and cell-type specific manner. We
will then administer the MC4R agonist setmelanotide to activate the receptor population to determine if MC4R
agonist activity on astrocytes and/or neurons in the hippocampus is able to prevent the development of HFD-
induced inflammation and cognitive dysfunction (Aim 1) or to reverse already existing neuroinflammation and
cognitive dysfunction in older mice that have been on a HFD and already have inflammation and cognitive
dysfunction (Aim 2). These studies will establish the cell type(s) responsible for the positive behavioral effects
and anti-inflammatory action of MC4R agonists in a HFD-based aging model. This is essential for informed
design of therapeutics to decrease neuroinflammation and increase healthspan.

Public health relevance
Chronic, low-levels of inflammation in the brain is seen in aging and is associated with cognitive dysfunction and abbreviated lifespan. These studies will yield insight into the ability of melanocortin receptor agonists acting at astrocytes in the brain to decrease inflammation and improve cognition. This knowledge is essential for the development of therapeutics that target inflammation in aging that causes significant compromise of quality of life.